Gain-of-function toxicity in alpha-1 antitrypsin deficient type 2 alveolar epithelial cells

Alpha-1 antitrypsin deficiency (AATD) is the sole monogenic cause of emphysema. AATD is caused by a
mutation in the SERPINA1 gene, which encodes for alpha-1 antitrypsin (AAT). AAT is produced mainly in
hepatocytes, from which it is secreted into the bloodstream to exert its primary function of inhibiting neutrophil
elastase in the lungs. The most common disease-causing mutation results in polymerogenic AAT, known as “Z
AAT”. Z AAT is trapped in the endoplasmic reticulum of hepatocytes, leading to proteotoxic liver disease and
reduced circulating AAT. AATD emphysema has classically been attributed to the protease-antiprotease
imbalance resulting from reduced circulating AAT. This hypothesis is complicated by two findings – 1) the
supplementation of functional AAT is less effective than expected if emphysema were solely caused by loss of
AAT and 2) there is evidence for Z AAT-induced proteotoxicity in extrahepatic cells. Type 2 alveolar epithelial
cells (AT2s) are the progenitor cells of the distal lung, renewing both themselves and type 1 alveolar epithelial
cells in response to injury. While Z AAT expression has been shown in multiple extrahepatic cell types, and
recently published single cell RNA sequencing data have shown high expression of SERPINA1 in AT2s, AAT
expression in AT2s remains unexplored. Our preliminary data identifies transcriptional evidence of an unfolded
protein response in AT2s from explanted human PiZZ lungs. The goal of this proposal is to elucidate the
functional and transcriptional impacts of Z AAT expression in AT2s, both at baseline and in the context of
cigarette smoke injury, and to determine whether Z AAT expression in AT2s contributes to the pathogenesis of
emphysema. Primary human AT2s are difficult to access pre-mortem. It is likewise challenging to maintain
primary human AT2s in vitro, limiting studies of their biology. To solve these challenges, we will utilize the
combination of a novel mouse model in Aim 1 and AATD patient-derived induced pluripotent stem cells (iPSCs)
in Aim 2. In Aim 1, we will chronically expose mice expressing human Z or “normal” SERPINA1 cDNA in AT2s
to cigarette smoke to investigate the accumulation of AAT and activation of the unfolded protein response in
AT2s, as well as histologically examine emphysema severity and immune cell infiltration. In Aim 2, we will to
generate AT2-like cells (iAT2s) from AATD patient-derived and CRISPR-corrected isogenic control iPSCs and
expose them to cigarette smoke. We will determine iAT2 dysfunction and genetic disease signature by
measuring AAT protein accumulation and secretion, activation of the unfolded protein response, functional
capacity, and global transcriptomic response to injury. Together these Aims will produce significant advances in
our understanding of AATD, and suggest the need for novel treatment strategies.

Public health relevance
Alpha-1 antitrypsin deficiency is the only monogenic cause of emphysema, and has classically been attributed to the loss of functional circulating alpha-1 antitrypsin protein. The goal of this proposal is to elucidate the impact of alpha-1 antitrypsin proteotoxicity in type II alveolar epithelial cells and how resulting type II alveolar epithelial cell dysfunction may contribute to emphysema pathobiology. Data generated from this proposal could indicate the necessity for novel treatment strategies for alpha-1 antitrypsin deficiency.